Deep Learning-Enabled Arterial Pulse Waveform Analysis Approach to Peripheral Artery Disease Diagnosis

PROJECT SUMMARY/ABSTRACT
Peripheral artery disease (PAD) is a highly prevalent vascular disease entailing high morbidity and mortality
risks. But, PAD is underdiagnosed with low primary care awareness. Conventional PAD diagnosis in clinical
settings is not suited to low-cost, high-throughput, and accurate PAD diagnosis. Noting that PAD alters arterial
pulse waveforms, the analysis of arterial pulse waveforms (called the pulse waveform analysis (PWA)) has the
potential for advancing the accuracy and convenience of PAD diagnosis. In particular, PWA can outperform
techniques built upon discrete features in the arterial pulse waveforms (e.g., ABI) by exploiting the arterial
pulse waveforms in their entirety. In addition, PWA can be realized with arterial pulse waveforms conveniently
measured at the extremity sites (e.g., arm and ankle, which are already being employed in ABI). Yet, PWA
involves trial-and-error-based empirical feature selection. Hence, PWA may be combined with modern deep
learning (DL) techniques to leverage the ability of DL to automatically select task-relevant features.
Successful training of a DL algorithm for PAD diagnosis requires massive labeled datasets associated
with longitudinal PAD progression collected from diverse PAD patients. However, only scarce (and possibly
non-longitudinal) datasets from a small number of patients may be available in reality. Now that arterial pulse
waveform is affected not only by PAD but also by the anatomical and arterial biomechanical characteristics of
the patient, insufficiency in datasets can deteriorate the robustness of the DL algorithm against disturbances
due to a wide range of anatomical and arterial biomechanical characteristics encountered in real-world PAD
patients obscuring the signatures of PAD in the arterial pulse waveforms. To address these obstacles, we
propose to realize a DL-enabled arterial PWA approach to PAD diagnosis by developing a novel computational
method for robust training of DL algorithms with scarce datasets. Our basic idea is to extend the conventional
domain-adversarial learning to guide DL training so as to foster the exploitation of latent features independent
of continuous anatomical and arterial biomechanical disturbances in diagnosing PAD. Specific aims include: (i)
to develop a continuous domain-adversarial regularization (CDAR) method for robust DL algorithm training with
scarce datasets; and (ii) to demonstrate the potential of the DL-enabled arterial PWA developed with the aid of
CDAR for detecting, localizing, and assessing the severity of PAD robustly against disturbances associated
with patient height and arterial stiffness in a resource-efficient in silico study. We will also estimate the amount
of datasets required to enable accurate and robust PAD diagnosis to inform our follow-up in vivo study. If
successful, the CDAR method and the DL-enabled PWA may be broadly applicable to the diagnosis of a range
of cardiovascular diseases. The success of this project will provide us with a strong justification for resource-
intensive in vivo assessment of the DL-enabled PWA approach to PAD diagnosis using datasets collected from
real PAD patients based on the sample size informed by the results of this project.

Public health relevance
PROJECT NARRATIVE Current techniques for peripheral artery disease (PAD) diagnosis are not suited to low-cost, high-throughput, and accurate screening and surveillance. Modern deep learning (DL) and arterial pulse waveform analysis can be combined to enhance the convenience and efficacy of PAD diagnosis but at the cost of unrealistically large datasets. In this project, we will study the feasibility of DL-enabled pulse waveform analysis for PAD diagnosis by developing a novel computational method to efficiently train DL algorithms using scare datasets.